Harnessing male peer networks to enhance engagement with HIV prevention: A largescale cluster randomized trial to increase HIV self-testing and PrEP uptake

PROJECT SUMMARY
Novel strategies are needed to engage men in Sub Saharan Africa (SSA) with HIV testing, treatment and
prevention services to drive the epidemic towards elimination. Suboptimal engagement with HIV prevention by
men increases their risk of HIV acquisition, and is an important driver of new HIV infections in women. HIV self-
testing (HIVST) addresses several key facility-based access barriers and HIVST distribution through leveraging
male peer networks for HIV prevention is feasible, acceptable and effective in SSA.
The objective of this project is to use an implementation science approach to establish the impact of HIVST
distribution through male social networks, with phone-based support and improved risk perception, on PrEP
uptake among men in Eastern Zimbabwe. The project will leverage infrastructure and data associated with 20-
year programme of HIV surveillance and behavioural research in a well-characterized population cohort hosted
by the Manicaland Centre for Public Health Research, Zimbabwe. The project is particularly opportune given
the very recent adoption of PrEP as a key component of the Zimbabwean national AIDS response and the
subsequent roll-out of PrEP in all local clinics.
The study will utilise a cluster randomised design of 44 clusters (22 Intervention:22 control) comprising on
average 81 men in each cluster (total N = 3591) followed for 6 months (giving >80% power to detect a difference
in PrEP initiation among men of 2% versus 8.5%). In intervention clusters we will identify initial distributors who
will receive an HIVST kit for personal use and HIVST kits to distribute to local peers. These peers can
subsequently become distributors, allowing the intervention to propagate through peer networks. A toll-free
helpline will provide pre- and post-test support and an SMS-based risk assessment will expedite PrEP initiation
at the clinic. We will conduct a performance (process) evaluation of the intervention. to assess implementation
fidelity, causal mechanisms underlying trial effectiveness including how characteristics of peer networks affect
outcomes. We will use the results of the study to quantify the population level impacts and cost-effectiveness of
male peer to peer HIVST distribution strategies on the uptake of PrEP in HIV hyper-endemic settings using a
fully calibrated individual-based mathematical model. The envisaged long-term impact of this research is the
development of a generalizable, multicomponent male peer-based HIVST and PrEP uptake model for settings
where HIV incidence is high.

Public health relevance
PROJECT NARRATIVE Effectively engaging men in HIV prevention remains one of the greatest challenges to driving the HIV epidemic towards elimination in sub-Saharan Africa. The objective of this project is to use an implementation science approach to establish the impact of HIV self-test distribution through male social networks, with innovative community-based support on pre-exposure prophylaxis (PrEP) uptake among men in Eastern Zimbabwe. Such a strategy aims to engage hard-to-reach men, decrease barriers to the uptake of male HIV testing prevention by reducing the need for engagement with clinics and seeks to expedite subsequent uptake of PrEP. We will use the findings of the study to model the potential population level impacts and cost-effectiveness of male peer to peer HIVST distribution strategies on the uptake of PrEP in HIV hyper-endemic settings.